Tissue chips for precision treatment of catecholaminergic polymorphic ventricular tachycardia - Diversity Supplement for Nnaemeka Justin Anyanwu

See Research Strategy.

Public health relevance
See Research Strategy.